Rapidly healing flow diverters using magnetic cell targeting for intracranial aneurysm treatment

Project Summary
This application focuses on advancing the field of intracranial flow diversion, that currently constitutes
approximately one-third of the treatment of unruptured intracranial aneurysms. There remain key limitations to
the technology that hinder expansion of the clinical application of these transformational devices, which to date
are limited in scope to unruptured, proximal aneurysms along the internal carotid artery. One major barrier is
device-related thrombosis, which can lead to thrombotic or embolic ischemic stroke. This requires administration
of dual anti-platelet therapy, which has the serious side effect of bleeding. Another major barrier is delayed
healing and aneurysm occlusion, which precludes treatment of acutely ruptured aneurysms and necessitates
prolonged anti-platelet therapy. We will break down these barriers to expanded utility by 1) developing a
ferromagnetic flow diverter to enable magnetic targeting of therapeutic agents and 2) testing the safety and
feasibility of rapid device healing by magnetic targeting of autologous endothelial cells. Studies have shown that
endothelialization of the aneurysm neck is critical for long term complete aneurysm occlusion and anti-platelet
therapy can be safely discontinued. We envision that, with our proposed approach, we will facilitate application
of novel, next-generation devices in ruptured aneurysms and in aneurysms distal to the Circle of Willis, and will
minimize thromboembolic risk. We have previously developed magnetic devices including stents, stent-grafts,
and vascular grafts and demonstrated their ability to capture and retain magnetically-labeled endothelial cells.
We will extend our magnetic cell targeting technologies to the application of rapid endothelialization of flow
diverters. Our robust and reproducible methods of statistical evaluation will directly assess 1) device integrity
and functionality, 2) device biocompatibility and hemocompatibility, 3) device magnetic properties, 4) magnetic
cell capture and retention to the devices, and 5) safety and feasibility of rapid endotheliazation and aneurysm
occlusion of magnetically endothelialized flow diverters in an in vivo aneurysm model. The discoveries from this
hypothesis-driven, multidisciplinary, clinical-translational research will provide a robust understanding of the
benefits conferred by rapid endothelization of flow diverters used to treat intracranial aneurysms. The goal of
this research is to reduce the complication rate associated with device-related thrombosis, prolonged anti-platelet
therapy, and delayed aneurysm healing and occlusion. If successful, neurointerventionalists will be able to use
flow diverters to treat a broader range of aneurysms safely and effectively. Optimizing outcomes and minimizing
complications will significantly improve patient care and save lives. A ferromagnetic flow diverter will also enable
future investigations of targeted delivery of other therapeutic agents. For example, fibrin for rapid aneurysm
occlusion, mesenchymal stem cells for rapid healing, and anti-platelet therapy to localize the effects and reduce
systemic bleeding risk. Such investigations have the potential to be transformative in the treatment of intracranial
aneurysms by significantly improving upon the current standard of care.

Public health relevance
Project Narrative This research proposal will develop a ferromagnetic flow diverter for treatment of intracranial aneurysms. This will enable magnetic targeting of therapeutic agents such as endothelial cells, which will lead to rapid healing and aneurysm occlusion. This has the potential to transform clinical treatment of intracranial aneurysms by improving the safety and efficacy of flow diversion across a wide spectrum of aneurysm types.